Bilateral integration of the auditory scene

ABSTRACT
The auditory system is posed with answering a challenging question: Does sound arriving at each ear originate
from a single source or multiple sources? To accomplish this perceptual feat, central auditory neural circuits
must accurately assess the spectral and temporal profile of bilateral sound signals to bind and integrate related
acoustic objects. Failure of this bilateral integrative process can account for many of the perceptual and
behavioral impairments that accompany auditory disorders, such as tinnitus, presbycusis and central auditory
processing disorders, which most of the population will experience over the lifespan. Surprisingly, the neural
mechanisms that enable this bilateral integration of acoustic information remain largely unknown, but likely
depend on an intricate balance of excitatory and inhibitory connections that link the two halves of the auditory
brain. Although commissural pathways have been well studied in auditory brainstem centers, much less is known
about the functional organization of commissural circuitry in higher centers of the auditory brain. Thus, the long-
term goals of our research are to understand the functional organization of the commissural pathways in the
processing of bilateral auditory information. Our primary objective here is to test a largely overlooked, yet
substantial, commissural auditory projection system, i.e. the pathway from the inferior colliculus to the
contralateral medial geniculate body. Our central hypothesis is that the medial geniculate body integrates
functionally and topographically aligned inputs from both the ipsilateral and contralateral inferior colliculi at a cell-
type specific level. Further, we hypothesize that the disruption of such bilateral tectothalamic convergence
results in deficits to the spectral and temporal processing of acoustic information in the medial geniculate body,
which contributes to disorders of the central auditory system. We will test our hypotheses by assessing: 1) the
functional neuroanatomy and 2) the neurophysiological impact of these contralateral tectothalamic pathways on
auditory processing, by employing modern, cell-type specific neuroanatomical and neurophysiological
approaches. As such, these studies are innovative since they address the unknown and unexplored functional
organization of the contralateral auditory tectothalamic pathways. Finally, the proposed experiments are
significant since they are expected to reveal mechanistic features of auditory processing that will have a positive
impact for neural diagnostics and treatments for central auditory impairments.

Public health relevance
NARRATIVE Many hearing and language disorders arise from pathological alterations to the central auditory pathways. This study is relevant to public health since it will investigate the hitherto overlooked contralateral auditory tectothalamic pathways as a neural substrate in these disorders. Therefore, this research is relevant to part of NIH’s mission, since it develops the basic knowledge that will lead to improved methods for diagnosing, preventing, and treating auditory disorders associated with aging, development, trauma, and neurodegeneration.